Delaying cognitive decline in mouse models of Alzheimer's disease via near-infrared light optogenetics

ABSTRACT
During sleep, the thalamus generates a characteristic brief pattern of 8-15 Hz electroencephalographic
(EEG) waves that predominantly occur during light stages of non-rapid eye-movement sleep (NREMS).
Reduced spindle may cause impaired learning and Mild Cognitive Impairment (MCI) in AD and is a
biomarker for early AD-related changes in brain dynamics. Conversely, promoting sleep oscillations by
transcranial stimulation enhances memory consolidation in MCI. By developing a set of novel,
noninvasive, bacteriophytochrome-based optogenetic tools to control cAMP synthesis (adenylate
cyclase, AC) and breakdown (phosphodiesterase, PDE), we will make spindles accessible for
noninvasive manipulations that spare other sleep rhythms. These enzymes are activated by light in the
so-called near-infrared optical window (NIRW). The NIRW light-activated modules are suitable for the
rapid yet long-lasting and noninvasive manipulation of cAMP in thalamic neurons in intact animals,
because NIRW light penetrates through mammalian skulls and brain tissues better than the light of any
other spectral region. We will examine a provocative novel hypothesis that cellular pathology and
cognitive decline caused by Alzheimer’s disease (AD) related mutations can be restored via enhancing
thalamocortical spindles waves during sleep in vivo. We will first develop novel noninvasive optogenetic
tools to manipulate AC and spindle oscillations (Aim 1). Then, we will examine whether NIRW-AC and
NIRW-PDE bi-directionally modulate the progression of AD–related neuropathology and cognitive
decline via their actions re: spindle wave regulations (Aim 2). Upon completion of this project, we will
have developed genetically encoded NIRW-light activated tools, allowing noninvasive manipulation in
deep brain regions of live animals. Results are expected to provide a sound basis for investigation in
disease models that involve spindle wave and cAMP aberrations, such as AD, and suggest novel non-
invasive intervention strategies to counteract brain dementias caused by AD.

Public health relevance
Project narrative We will engineer bacteriophytochrome-based near-infrared optical window (NIRW)-activated enzymes to control cAMP synthesis and breakdown, and apply this novel tool in vivo to bi- directionally manipulate sleep spindle waves in mouse models of Alzheimer’s disease (AD) to test a provocative hypothesis that cellular pathology and cognitive decline caused by Alzheimer’s disease (AD) related mutations can be restored via enhancing thalamocortical spindles waves during sleep.